BIOASSAY OF PTH AND RIA OF CT IN FSH AND NORMAL PREGNANCY

Pregnancy study discontinued, no recruitment. For remainder, study to determine if bioassayable parathyroid hormone is normal or high in familial benign hypercalcemia and if parathyroid hormone suppression and calcitonin stimulation after calcium infusion are normal.